A Citizen-Science Approach to Occupational Hazard Assessment

Abstract
Comprehensive exposure assessment in the field of occupational health has been limited, historically, by a
combination of technological, financial, and human factors. The cost and complexity of personal sampling
technology limits a single industrial hygienist (IH) to making, at most, about 10 measurements of personal
airborne exposure each day. Many hygienists can work together to produce a larger exposure dataset; however,
the cost to assess exposures for every worker in a facility is exorbitant under the current paradigm. These
limitations hinder our ability to identify workers at risk of overexposure; they also lead to imprecise effect
estimates in occupational epidemiology. Collectively, these limitations lead to greater risks of poor health
outcomes among workers.
This project seeks to develop new technologic and methodologic approaches for assessing worker exposure to
occupational air pollutants. We will develop a wearable exposure monitor for aerosol and vapor hazards that is
immediately deployable “out of the box” with minimal user training. Further, the monitor will be designed to take
reference-quality measurements of tens to potentially hundreds of different airborne compounds. We also seek
to transform the practice of industrial hygiene by further leveraging support and participation of the workers
themselves through a citizen-science approach to hazard identification and exposure assessment. Successful
completion of this research will enable dramatically greater sample sizes for personal exposure measurements
in the workplace, which, in turn, will promote more better professional judgement, more efficient hazard control,
more effective epidemiology, and improved worker health. A second goal is to demonstrate the potential for
citizen science to improve worker comprehension of and engagement in workplace safety culture. The project
has two aims. The first is to develop a simple, inexpensive, “smart” sampling device for comprehensive
assessment of personal exposures to aerosol and vapor hazards. The device will be small and easy to deploy
and wear while containing quality-assurance features necessary to meet the performance of accepted standard
reference methods (active flow control, fault monitoring, user compliance). The second aim is to conduct a series
of field deployments to evaluate whether the new technology, when used with a citizen science approach, can
promote better engagement in and knowledge of workplace health and safety among workers, organizations,
and industrial hygienists. We hypothesize that the citizen-science approach will change worker- and
organizational-level attitudes and behaviors relevant to occupational hazard assessment and mitigation. We also
hypothesize that industrial hygienists will improve their ability to accurately assign workers to exposure control
categories, when presented with the comprehensive exposure data we generate. Successful completion of this
work will validate a new technology for workplace hazard assessment while demonstrating the utility of a citizen
science approach to increase knowledge and awareness of health and safety in the workplace.

Public health relevance
Narrative Exposure measurement in the field of occupational health is limited by technological, financial, and human factors. These limitations hinder our ability to identify workers at risk of overexposure, which increases the risks of poor health outcomes. This research will develop new, “smart” technology for assessment of workplace airborne hazards while demonstrating the utility of a citizen science approach to increase knowledge and awareness of health and safety in the workplace among workers and improve the practice of industrial hygiene.